BIOSTATISTICS CORE

The Data Management Core at the USC ADRC provides high quality data management and biostatistical consulting to the research projects, pilot projects and the cores of the ADRC. The specific aims are: (1) Implement and maintain Web-based data entry, data management, and patient- and specimen-tracking system; (2) Train and work with staff of the Clinical, Neuropathology, Spanish-Speaking Satellite, and Imaging Cores to ensure timely and accurate data entry and management; (3) Work with the National Alzheimer Coordinating Center (NACC) to provide timely, accurate, ant complete submission of local data; (4) Provide data reports to core staff and investigators on a routine and as needed basis; (5) Provide biostatistical consulting in the design, coordination, and analyses of ADRC-related projects, including pilot projects.